Single cell analysis of dysregulated inducible DNA amplifications of immune response genes in Down syndrome

ABSTRACT.
Despite knowing for more than 60 years that three copies of chromosome 21 (chr21, T21) is the genetic cause
of Down syndrome (DS), we still know relatively little about how T21 drives the vast majority of DS
pathophysiology. Over the last several decades, alterations in the response to immune signaling have been
identified in T21 cells, mouse models of DS and individuals with DS. Indeed, we have shown that the interferon
(IFN) response is constitutively active in T21 cells, leading to an interferonopathy-like state of global immune
dysregulation, likely due to the presence of four IFN receptors (IFNRs) in a single locus on chr21. Recently, we
identified the IFNR locus as a target of directed transient site-specific gene amplification (TSSG) in response to
immune activation. Importantly, we found that while the IFNR cluster is subject to TSSG in healthy cells, this
process is impaired in T21 cells. Our work to understand rereplication of the IFNR locus has uncovered that
innate immune signaling drives rereplication of a network of immune response genes that may be dysregulated
in DS. This project will test the hypothesis that innate immune activation drives a heterogenous program
of inducible DNA rereplication of immune response loci which is dysregulated by T21.
This project addresses Component 1 of the INCLUDE project, targeted high risk – high reward basic science
studies in areas highly relevant to DS and aligns closely with the NIAID interest in examination of immune system
dysregulation in Down syndrome and its molecular basis. Dysregulation of the immune system and interferon
signaling in T21 is a key contributor to many comorbidities associated with DS and our project will delineate
further avenues of dysregulation in the immune response in T21 cells. This work will employ a novel single cell
amplicon sequencing approach which we leverage to identify transient changes in copy number for the first time.
This work will determine how many immune response genes are amplified during immune activation and how
this is dysregulated in T21. Furthermore, we will determine if the innate immune driven rereplication program is
conserved in primary mouse T cells and if it is dysregulated in a mouse model of DS.
Given the novelty of our observation and hypothesis, this proposal seeks to answer a number of questions
regarding the innate immune program in T21 including: 1) How do T21 cells suppress TSSG of the immune
response? 2) How many immune response loci are amplified in the same cell at the same time and is
this heterogeneity different in T21? 3.) Does T21 initiate a different immune response gene amplification
program?
Using human cell culture models and a novel amplicon sequencing approach we will comprehensively determine
the extent of dysregulation of DNA rereplication of the immune response program in T21.

Public health relevance
NARRATIVE This project will test the hypothesis that that innate immune activation drives a heterogenous program of inducible DNA rereplication of immune response loci which is dysregulated by trisomy 21 (T21) and Down syndrome. We have identified a program of immune response genes with mechanistic characteristics suggesting they will undergo transient amplification during an immune response. To test our hypothesis, we will employ human and mouse D21 and T21 models and perform single-cell amplicon sequencing to simultaneously determine the copy number of 100 immune-related genes in response to innate immune signaling.